Single-cell longitudinal analysis of regeneration in human pancreatic slices

PROJECT SUMMARY
We have described a subpopulation of human pancreatic ductal cells with progenitor-like characteristics.
These cells can be sorted using antibodies against the BMP receptor 1A (ALK3bright+) and P2RY1, a surrogate
surface marker for PDX1 identified by our team. ALK3bright+/P2RY1+ cells proliferate when exposed to BMP-7,
and differentiate into all adult pancreatic cell types, including functional β-cells, upon BMP-7 withdrawal.
scRNAseq of the ALK3bright+ fraction of human pancreatic donors confirmed the existence of clusters with
progenitor-like features, with substantial evidence suggesting that such features may be acquired by de-
differentiation. When transplanted into immune-deficient mice, sorted cell populations enriched in markers
differentially expressed in these clusters self-organize into ‘micro-pancreata’ with native-like cytoarchitecture and
functional endocrine cells. More recently, we have developed the means to study the dynamic processes of
progenitor cell-dependent regeneration using human pancreatic slices (HPSs). We have achieved functional
long-term (>10d) culture of HPSs, which allows for the longitudinal tracking of β-cell regeneration in a setting
that is widely considered the closest approximation in vitro to a native pancreas. BMP signaling-dependent
regeneration was established in slices from healthy and, more importantly, T1D and T2D donors.
Numerous single-cell analyses of the pancreas, included our own, support the emerging view that specific
lineages are in a state of flux between differentiation stages. However, all these analyses only offer a snapshot
of the tissue at any given time point. Conclusions about potential developmental/regeneration paths are
exclusively based on bioinformatics inferences. We hypothesize that the combination of long-term organotypic
culture with lineage-tracing in vitro and sequential single-cell analyses will allow us, for the first time, to
dynamically map cell fate changes –e.g., by conducting longitudinal scRNAseq of slices from the same donor
across multiple time points after BMP-7 addition. Furthermore, we contend that this system will enable the real-
time visualization and in-depth, single-cell resolution study of potential de-differentiation events, should they
happen in response to different sources of stress in human slices. These approaches offer a wealth of new
research possibilities that were downright unfeasible prior to the development of these methods. Our research
design is expected to help us realize the full potential of single-cell transcriptomics to unveil dynamic biological
processes, model human pancreatic disease, and, ultimately, enable the development of novel therapeutic
approaches to induce regeneration. We will test the above hypotheses by pursuing the following specific aims:
(1) Longitudinal scRNAseq of same-donor T1D/T2D HPSs following stimulation of the BMP pathway. (2) Study
of the effect of stress, inflammation and de-differentiation on BMP-7-mediated induction of β-cell formation in
HPSs; (3) Functional characterization of neogenic β-cells through “slice-on-a-chip” approaches; and (4)
Determination of in vivo regeneration potential of progenitor cells sorted from healthy and T1D/T2D donors using
a xenotransplantation model.

Public health relevance
NARRATIVE The different cellular compartments of the pancreas have a high degree of plasticity, which, if harnessed, could have important therapeutic applications for beta cell regeneration in type 1 and 2 diabetes. Our proposal aims at the high-resolution characterization of a well-known mechanism of pancreatic beta cell regeneration, namely, the activation of progenitor cells in the ductal tree. To that end, we will use a novel means of culturing live pancreatic tissue (human pancreatic slices) that keeps the cytoarchitecture of the organ intact. This will allow us to study regeneration in real time as if having a window into the native organ. These studies are highly relevant to the mission of the National Institute of Diabetes and Digestive and Kidney Diseases (NIDDK) and may ultimately have a significant impact on public health.